Training Program in Translational Cardiovascular Science

PROJECT SUMMARY/ABSTRACT
This application seeks renewal for Years 21-25 of the Training Program in Translational Cardiovascular
Science (TPTCS) within the School of Medicine and Public Health Cardiovascular Research Center (CVRC) at
the University of Wisconsin-Madison. The CVRC is a campus-wide interdisciplinary research center with
faculty and research members from 31 departments in seven schools and colleges, providing a rich
environment targeting cardiovascular disease through basic research, clinical investigation, diagnosis and
therapy, and public education. The TPTCS training program uniquely creates basic research training for
postdoctoral MDs and PhDs (four positions) as well as predoctoral trainees (five positions) with the goal of
training scientists who will be capable of thinking and working “from molecule to bedside.” The practical
immediate objectives are to attract and train clinicians in basic research, and to attract and train graduate and
postdoctoral (PhD) students in clinically motivated basic science. The TPTCS aims to appoint physicians as
part of their resident and fellow training to half the postdoctoral positions. One of the long-standing strengths of
the program emerging from annual program evaluation is its integration of training among predoctoral students,
basic science postdoctoral trainees, and clinical fellows who work side-by-side in journal clubs, in seminar
series, and at the bench in laboratories. This blending and sharing of different trainee perspectives is
foundational to the goals of the program and creates esprit de corps. The 27 trainers of the TPTCS have been
selected from members of the CVRC for the clinical relevance of their science in the focus areas (heart
failure/regenerative medicine, arrhythmias/ion channel research, and atherosclerosis/vascular biology), their
training records, and the overall robustness and activity of their peer-reviewed research programs. Training
takes place at the University of Wisconsin-Madison and exploits the strong institutional support and
environment for such training, as well as the established working relationships between clinical and basic
science departments and faculty both within the School of Medicine and Public Health and the University at
large. Trainers and trainees all participate in core activities that define the program as a cohesive entity.
Several innovations are introduced in this renewal, including enhanced clinical integration for the basic science
trainees and greater professional development opportunities to prepare all trainees for the next stages in their
careers. Appointees to the program to date are extremely strong and program outcomes have been excellent.
The scientists and physician-scientists trained in this translational cardiovascular science program are in
unique positions to apply basic scientific knowledge to benefit patients with cardiovascular disease, the
foremost cause of mortality among Americans.

Public health relevance
PROJECT NARRATIVE Cardiovascular diseases leading to heart failure, heart attack, and sudden death due to catastrophic arrhythmias (irregular heartbeat) remain the leading cause of death among American adults. The Training Program in Translational Cardiovascular Science fills a unique and critical gap by bringing together basic and clinical researchers and trainees with the goal of training versatile scientists who will be capable of thinking across disciplines and working from “molecule to bedside” to find new cures, treatments and fundamental advances in heart and vascular function.